A nanocoating for continuous disinfection of frequently touched surfaces

A nanocoating for continuous disinfection of frequently touched surfaces
Healthcare-associated infections (HAIs) represent a constant risk for patients and healthcare workers and have
a large impact on public health. Fomites, inanimate surfaces contaminated by pathogens, are a passive source
of infection and their role in infection propagation in hospitals has been recognized as an important health
problem. Fomites can be contaminated with microbes by direct contact with body fluids such as blood or saliva
or by airborne microbial particles, like sneeze droplets. In the nosocomial setting, noncritical frequently touched
surfaces (FTS) such as doorknobs, countertops, bedrails, and bedside tables may contribute to fomite-mediated
HAIs by contaminating the hands of health care providers or by contact with medical equipment that will
subsequently come in contact with patients. To prevent and reduce the risk of HAIs transmission, the low-level
disinfection (LLD) of FTS is a widely used strategy. LLD aims to inactivate vegetative bacteria, virus, and fungi,
but not spores. To do so, liquid disinfectants or wipes are used to wet the surface for the amount of time
recommended by the manufacturer, usually 10 minutes or less. LLD has been found to be highly effective (>4-
log10 reduction) in removing/inactivating epidemiologically important pathogens. Nevertheless, since
recontamination can occur at any moment after cleaning, an important drawback of LLD is the need for repeated
disinfectant application. To address this, here we propose the use of a nanocoating (NC) for continuous LLD of
FTS. The NC will be able to attain >4-log10 reduction of gram positive and gram-negative bacteria in 15 minutes
or less by using visible light to kill pathogens via oxidative stress. It will be formulated for an environmental-
friendly application and will keep its antibacterial activity for about 60 days. The specific aims to reach the
objective are:
AIM 1. Formulation and optimization of NCs. The material will be formulated and optimized for high bacterial
reduction (>4-log10) in 15 min or less against S. aureus and E. coli.
AIM 2. Characterization and optimization of NC properties. The mechanical, physiochemical, and
antibacterial properties of new and aged coatings will be assessed to optimize performance and duration.
AIM 3. In vitro and in vivo studies to assess the safeness of NCs. Studies using human cells and animal
models will be performed to evaluate adverse health effects of NCs.

Public health relevance
Research shows that many healthcare-associated infections (HAIs) can be indirectly transmitted via fomites, inanimate surfaces such as doorknobs, countertops, bedrails, and bedside tables, which are a common occurrence in the hospital setting. It has been demonstrated that fomites can harbor pathogenic microorganisms for extended periods of time, and that the most common disinfection methods are not totally effective since recontamination can occur at any moment after the application of disinfectants. Considering this, our long-term goal is to develop a nanocoating with sustained self-disinfecting capabilities activated by visible light to reduce fomite-mediated HAIs transmission.